Flow Cytometry

FCSR Summary
The Sidney Kimmel Cancer Center Flow Cytometry Shared Resource (FCSR) provides state-of-the-art
fluorescence activated cell sorting and analysis capabilities to investigators of the Sidney Kimmel Cancer
Center and the Philadelphia region. The most commonly used applications are multi-color cell surface
phenotyping, detection of intracellular cytokines and signaling molecules, transfection measurements, studies
of apoptosis, cell cycle analysis, cell proliferation, and real time analysis of Ca2+ mobilization kinetics. The
sorters, analyzers, and workstations allow for affordable, reliable, and accurate characterization of a wide
variety of biological samples. These services provided can be tailored to suit experimental designs in a variety
of fields. FCSR provides consultation on current protocols, analysis techniques, and data presentation. This
resource plays a critical role in assisting SKCC members performing various research projects directly related
to the understanding of the biology and treatment of cancer. Current goals of the facility include: 1) Provide
high-quality and affordably priced services for analytical cytometry data acquisition and cytometric cell sorting
of various types of biological particles; 2) Consult with SKCC members to determine analytical cytometry
needs, aid in the development of appropriate protocols and techniques, and provide technical support for
analysis including data analysis and interpretation and/or training in using BD FACS DIVA and FlowJo
softwares; 3) Provide training to SKCC members for 24/7 use of automated analytical flow cytometry
instrumentation for competent and efficient routine analysis.